YEAST CELL WALL PROTEINS

The 2D gel center has trained a number of investigators in the running of two-dimensional gels. Investigators 3 - 7 (above) have been trained in the Resource Center. Kim Campbell has been trained to separate proteins in the first dimension on the basis of protein charge (isoelectric focusing) and in the second dimension on the basis of apparent molecular weight. Kim has also been trained to pour and cast second dimension gels. The Center provided assistance in interpreting separated protein patterns.